The role of mouse auditory cortex and inferior colliculus in recovery from hearing loss

The ability to localize sound is vital for communicating with other people. Sound localization usually depends
on input from both ears, and so it is especially impaired by unilateral hearing loss, which is caused by common
conditions like ear infection. The brain can compensate by re-interpreting cues from the damaged ear or
favoring input from the intact ear. These neural mechanisms of recovery are incompletely understood but the
projection from auditory cortex from inferior colliculus has been shown to be necessary for spatial hearing after
hearing loss. However, these studies have not examined the electrophysiological changes that occur after
hearing loss. Therefore, the exact role of the signals being sent from auditory cortex to inferior colliculus after
hearing loss are not yet understood. To answer this question, my sponsor’s lab has developed a spatial
hearing behavior paradigm in which mice must locate sound. Mice with unilateral hearing loss are initially
impaired at this task but show robust recovery. Using this paradigm, I will record in auditory cortex and inferior
colliculus of mice over the course of behavioral recovery to determine how changes in neural activity drive
changes in behavior. My central hypothesis is that after hearing loss, auditory cortex drives recovery of spatial
tuning in inferior colliculus neurons, allowing recovery of spatial hearing despite degraded information from the
periphery. The goal of this project is to determine how spatial tuning of cortical and collicular neurons enable
behavioral recovery, which I will address through two aims. Aim 1 is to determine how auditory cortex and
inferior colliculus recover spatial tuning after hearing loss, which I will achieve through chronic
electrophysiological recording in these regions before and during recovery from hearing loss and by comparing
between mice performing the behavior task versus animals passively listening to sound. Aim 2 is to determine
the causal role of auditory cortex in recovery from hearing loss, in which I will use chemogenetic manipulations
to suppress auditory cortex activity and to determine the effects on inferior colliculus spatial tuning. This project
will elucidate the neural changes that enable recovery after sensory loss in freely moving mice. Ultimately, this
research will allow us to develop treatments for hearing loss that leverage the brain’s plasticity. Moreover, this
fellowship will provide me with crucial training in auditory neuroscience and animal behavior from my sponsor
Dr. Chris Rodgers and my co-sponsor Dr. Robert Liu. I will have support from the broad community of systems
neuroscientists at Emory, including Dr. Malavika Murugan who writes a letter of support. This training will
prepare me for postdoctoral research and to become an independent investigator.

Public health relevance
PROJECT NARRATIVE After hearing loss, people struggle to process sound and to communicate, but they can partially recover these abilities through processes in the brain that are not fully understood. In this project, I will determine how auditory brain regions enable recovery in a mouse model of hearing loss. Understanding the brain’s capacity to recover from sensory loss will enable new treatments for hearing impairment.